Impact of supportive policies on minority stress, drinking and health among women

Abstract. This is an administrative supplement request for the approved supplement 3R01AA013328-14. Over the past several decades research has clearly demonstrated that compared with their heterosexual counterparts, sexual minority women (SMW; lesbian, bisexual) are at substantially higher risk of hazardous drinking (HD; i.e., heavy average drinking, heavy episodic drinking, intoxication, adverse drinking consequences and alcohol dependence symptoms). HD-related risks among women are associated with stress. Added to the stress experienced by women in the general population are stressors unique to having a minority sexual identity, such as stigma and discrimination. Sexual minority stressors are likely amplified by COVID-19 (C-19). For the past 20 years, the Chicago Health and Life Experiences of Women (CHLEW) study has focused on identifying risk and protective factors and the mechanisms by which these factors influence HD among SMW. The parent grant for this supplement (CHLEW Waves 4 & 5; R01 AA013328) focuses on the impact of an historic structural-level event (i.e., legalization of same-sex marriage) assumed to be supportive of SMW and their health. We are now confronted by another historic macro-level event—the C-19 pandemic. In this case the impact is assumed to be threatening rather than supportive. To rapidly improve understanding of critical social and behavioral aspects of the pandemic relative to HD among SMW, we will add an online C-19 module to W5 of the CHLEW, currently underway. We will compare drinking outcomes in W5 with those assessed in W4 (2018- 19), before the pandemic. The online C-19-specific questions will complement the unique and rich data on social and behavioral factors already collected that are highly relevant to the pandemic. The aim is to: Prepare data generated from the project to be deposited and shared with the National Data Archive and add global identifiers for our participants who agree to share this information. Results of the study will enhance understanding of the pandemic's personal and economic costs and behavioral outcomes in an already vulnerable population.

Public health relevance
Public Health Relevance The proposed research takes advantage of a long-established cohort of lesbian and bisexual women to identify impacts of COVID-19 and distinguish these impacts from other major influencers of hazardous drinking assessed in an on-going longitudinal study. Information gained can inform treatment aimed at reducing the potentially long-term harmful impacts of the pandemic. Contributing the data to the National Data Archive may assist other researchers in developing interventions to combat the negative impact of COVID-19.